The activation of benzoxaborole prodrug AN15368, a clinical candidate for Chagas disease

PROJECT SUMMARY
Chagas disease, caused by the protozoan parasite Trypanosoma cruzi, is endemic in the Americas, but has also
globalized due to human migration. Despite being one of the major causes of infection-induced heart disease
worldwide, current therapies for Chagas disease have inconsistent efficacy and frequent side effects. A major
contributor to treatment failure is thought to be the transiently dormant intracellular forms of T. cruzi that are resistant
to otherwise highly effective trypanocidal compounds. The newly discovered benzoxaborole AN15368 represents the
first extensively validated and safe clinical candidate for the treatment of Chagas disease. With the mRNA processing
pathway as the apparent target, AN15368 acts as a prodrug that requires cleavage by parasite serine carboxypeptidases
(TcCBPs) to yield the active metabolite. This proposal aims to gain additional understanding of this processing step for
AN15368 as a prodrug, as well as to assess the potential for acquired resistance as this compound proceeds toward
human clinical trials.
Aim 1 will take advantage of our well-established quantitative mass spectrometry platform to extensively study
the kinetics of AN15368 metabolism in amastigotes and epimastigotes, the two proliferative life stages of T. cruzi. A
concentration-gradient model will be constructed based on this study to test the hypothesis that only the prodrug, but
not the processed form, can enter T. cruzi efficiently and once processed, accumulates therein. Furthermore, these
kinetic studies will address the differential susceptibility of epimastigotes and amastigotes to AN15368 to further
understand the process of prodrug metabolism. Aim 2 will focus on the breadth of susceptibility to the prodrug in the
amastigote populations. A fluorogenic substrate will be developed to allow for the quantitation of prodrug activation in
individual amastigotes, including the transient dormant ones. We will test the hypothesis that the susceptibility to this
prodrug is broad in amastigotes, including those in dormancy. Lastly, since the prodrug feature brings AN15368 the
liability of acquiring selected resistance via loss of the processing pathway, we propose to carry out Aim 3 to
comprehensively monitor the outcome of infection when TcCBPs are disrupted, with and without AN15368 treatment.
This will provide an assessment for the risk of this resistance if developed.
The proposed work will enhance our understanding of how prodrug AN15368 achieves sterile cure of T. cruzi
infection, and will be the first study attempting to quantify a metabolic process in dormant parasites to address drug-
mediated cure. The results of these studies are expected to provide insights into the high therapeutic potential of
benzoxaboroles in this and other parasitic infection, as well as one of the risks for induction of drug resistance to this
class of compounds and thus inform on the safety and efficacy of this clinical candidate.

Public health relevance
PROJECT NARRATIVE We have recently identified a new clinical candidate for the potential treatment of Chagas disease, a result of infection of humans and other mammals by the parasite, Trypanosoma cruzi. The work proposed in this application will investigate the uptake and metabolism of this drug by T. cruzi. These studies are expected to provide new insights into the mechanisms of drug action and the potential for failure of this promising treatment.